A Novel Multi-Lineage Human Intestinal Organoid Screening Platform for Drug Discovery and Preclinical Testing

ABSTRACT
The drug development pipeline currently tests drug candidates on simple cell monolayers or animal models;
however, 90% of new drugs fail clinical trials, wasting millions of dollars and leaving patients in need. There is
an urgent need for better models of human physiology that can accurately mimic the toxicity and efficacy of
drug candidates in preclinical drug testing. To address this need, our interdisciplinary team, consisting of Intero
Biosystems, Inc. and the University of Michigan, has developed the first stem cell-derived Human Intestinal
Organoid (HIO) that contains many of the tissue types found in the native intestine, including the inner lining of
the intestine and supporting tissues such as functional smooth muscle that can undergo peristalsis, perfusable
blood vessels, and neurons—effectively mimicking the human intestine “in a dish.” In this proposal, we will first
validate and optimize the HIO system for use in assays for cell viability and cytotoxicity, which are common in
the preclinical space. Next, we will develop a model of intestinal fibrosis for drug efficacy testing. Due to the
complexity of this HIO model, it is possible to induce fibrosis with the addition of TGFβ, and a scalable qPCR
panel will be developed to assess fibrotic induction. This proposal aims to make significant progress in
positioning HIOs as a powerful microphysiological system that could revolutionize preclinical drug testing.

Public health relevance
NARRATIVE The drug development pipeline currently tests drug candidates in animals and on simple cell models before seeking FDA approval for clinical trials, yet 90% of new drugs fail clinical trials. We have developed the first stem cell derived Human Intestinal Organoid (HIO) to contain many tissue types found in the native intestine, including inner lining of the intestine, and supporting tissue including smooth muscle, blood vessels, and neurons, mimicking the human intestine “in a dish”. These HIO can model complex intestinal diseases that cannot be accurately mimicked in animals, such as fibrosis, and through this STTR application, we will develop these organoids into a rapid screening platform to test drug candidates in a preclinical setting.